PROSTATE, LUNG, COLORECTAL AND OVARIAN (PLCO) CANCER SCREENING TRIAL

The following hypotheses will be tested: a) screening for prostate cancer with digital rectal exam and PSA blood test will reduce the mortality from prostate cancer; b) screening for lung cancer with chest x-ray will reduce mortality from lung cancer; c) screening for colorectal cancer with sigmoidoscopy will reduce cancer, and d) screening for ovarian cancer with transvaginal ultrasound and CA-125 will reduce mortality from ovarian cancer. All subjects will be age 55 - 74.